Structure and Mechanism of HERC5-dependent ISGylation

Project Summary
Mammalian cells have developed an elaborate network of immunoproteins that serve to identify and combat viral
pathogens. Interferon-stimulated gene 15 (ISG15) is a 17.2 kDa tandem ubiquitin-like protein that is used by specific E1–
E2–E3 ubiquitin cascade enzymes to interfere with the activity of viral proteins. Recent biochemical studies have
demonstrated how the HECT and RCC1-containing protein 5 (HERC5) E3 ligase regulates ISG15 signaling in response to
SARS-CoV-2, hepatitis C (HCV), influenza-A (IAV), human immunodeficiency virus (HIV), and other viral infections. While
the immunological role of HERC5-dependent ISGylation is well established, the molecular mechanisms used by HERC5 to
catalyze the specific and timely attachment of ISG15 to proteins in response to a viral infection remain unclear. It is
paramount that we understand how HERC5 works at the atomic level to aid in the future development of therapies to
treat viral infections and to enhance human health.
The objective of this project is to understand the structural and biochemical basis for HERC5-dependent IGSylation. To
date there have been no structural studies reported for HERC5. We will elucidate the unique mechanism used by HERC5
to attach ISG15 on to viral substrates. HERC5 is a unique member of the Homologous to E6AP C-Terminus (HECT) E3
ubiquitin ligases that contains the characteristic HECT domain, consisting of an N-terminal lobe and a C-terminal lobe, that
is responsible for catalyzing the covalent attachment of ISG15 to a target protein. Currently the mechanism that HERC5
uses and the identities of specific residues in and around the active site required to catalyze the attachment of ISG15 with
is unclear. The long-term scientific goal of the PI is to investigate the 3D structures and underlying enzymology for HERC5
to learn how this enzyme selectively and specifically attaches ISG15 to viral proteins as part of the host’s innate immune
response.
The major foci of this proposal will be to determine the catalytic mechanism of HERC5 using structural and biophysical
approaches (Aim 1), and to examine HERC5 complex with ISG15 and the E2 enzyme UBE2L6 (Aim 2). Our preliminary
studies using NMR spectroscopy and other biochemical approaches suggest that the novel mechanism of HERC5 is found
exclusively in the HECT domain C-terminal lobe that contain the absolutely conserved catalytic cysteine required to
ISGylate viral proteins. Building on our established track-record of examining the mechanisms of other members of the
HECT E3 ubiquitin ligases, the inherent difference of HERC5 being ISG15-specific and not able to catalyze ubiquitin transfer
provide an enticing opportunity to expand our current understanding of HECT-dependent activity and how their
dysfunctions cause disease. Our findings will offer new insight into the molecular mechanisms used by the HECT E3 ligase
HERC5 and help us learn how and why this enzyme works in response to a viral infection. Undergraduate students will be
an essential part of the success of this R15 AREA research project. The contribution from Biochemistry and Molecular
Biology (BCMB) undergraduate students at Clark University will be integral to the completion of the proposed work and,
as a result of their importance in this research program, they will receive extensive guidance from the PI, will share in
manuscript preparation and publication authorship, and present their work at national and international research
conferences.

Public health relevance
Project Narrative HERC5 is a unique HECT (Homologous to E6AP C-Terminus) E3 ubiquitin ligase that is responsible for the specific attachment of ISG15 (Interferon Stimulated Gene 15), a tandem ubiquitin-like protein, on to viral proteins as part of the host’s innate immune response. Our current project deciphers the unique mechanism used by HERC5 to direct the ISGylation of viral proteins, and elucidates the underlying biochemical and structural basis for the anti-viral role of HERC5 that can aid in the development of future viral treatments and improve human health. This equipment supplement requests a new AKTA Pure 25 M FPLC System to replace the 8-year-old system that has become increasingly unreliable.